Epigenetic regulation of alcoholic liver fibrosis

DESCRIPTION (provided by applicant): The understanding of molecular mechanisms that underlie myofibroblastic transdifferentiation (MTD) of hepatic stellate cells (HSC), is a prerequisite for development of new therapeutic modalities for alcoholic liver cinliosis. We have approached this goal from a unique standpoint of cell fate regulation of pluripotent mesenchymal cells. In this end, we discovered "adipogenic regulation" is essential for HSC quiescence and loss of this regulation results in MTD. As such, restoration ofthe expression of PPARγ, the master regulator of adipogenesis in MFB achieves a phenotypic reversal of the cells to quiescent HSC, and this effect is completely abrogated by co-transduction of a dominant negative mutant of PPARγ. In search for the mechanisms of PPARγ repression in MTD, an international collaboration by Tsukamoto and Mann laboratories disclosed major contributions of two epigenetic regulators: the methyl CpG binding protein MeCP2 which causes HP1a recmitment to methylated H3K9 at PPARγ promoter;and the polycomb repressive complex 2 (PRC2) methyltransferase EZH2 which di- and tri-methylate H3K27 as another mechanism of powerful gene silencing. We also demonstrates a loss ofthe negative control with miR132 as a novel mechanism of MeCP2 induction which in turn positively regulates the expression of EZH2 in MTD. The proposed collaborative research is aimed at extending these ground-breaking findings on epigenetic regulation of MTD shown in culture-activated HSC, to MTD in alcoholic liver fibrogenesis. Toward this goal, the following specific aims will be pursued: 1) to determine whether MeCP2 and EZH2 mediated epigenetic mechanisms are evident in activated HSC/MFB isolated from the mouse model of alcoholic liver fibrosis;2) to determine whether MeCP2 knockout or a EZH2 inhibitor specifically targeted to activated HSC/MFB ameliorates alcoholic liver fibrosis;3) to validate MeCP2 and EZH2 mediated epigenetic regulation in activated HSC/MFB in alcoholic liver fibrosis in man. We believe that the proposed study will uncover novel mechanisms of alcoholic liver fibrosis and important therapeutic targets for the disease. PUBLIC HELATH RELEVANCE: The proposed international collaboration will disclose new information conceming how alcohol-induced cirrhosis of the liver develops and will test novel therapeutic approaches for the disease in animal models. It is our long-term goal that such treatment options will be made available for patients suffering from cirrhosis.